Developing, implementing, and evaluating a mixed-methods community-based participatory research sleep intervention in families with K-1st grade children living on the Blackfeet Indian Reservation

Candidate: The overall goal of this K01 career development proposal is to provide me with the
research and training needed to become a leader in the field of sleep intervention and health
disparities research in American Indian (AI) populations. As my work has moved in to studying child sleep,
it is clear that sleep intervention research is severely lacking. In addition, there are no studies that have been
done in any AI community. My preliminary work on the Blackfeet reservation has shown that children do not
get enough nightly sleep. These findings helped shape the direction for this K01 proposal to develop a novel
sleep intervention grounded in cultural values to improve total sleep time (TST) in families that have children in
the K-1st grade. The K01 research and training fulfills defined missions of the NHLBI by understanding sleep
disparities and investigating factors that account for differences in a high risk, underserved AI community, and
fostering the training of an AI investigator on a trajectory to becoming an independently funded researcher. My
training will be targeted to two key areas (among others): 1) sleep and 2) training in mixed-methods research
and randomized controlled trials with mentoring from local and national content experts. I will also enhance my
understanding in two areas related to sleep: nutrition and stress/trauma. Developing and pilot-testing
community-based sleep strategies grounded in AI cultural values, in combination with my training plan, will
uniquely position me for a successful independent research career in sleep intervention research with
underserved populations. Collectively, this K01 award will position me to develop an R01 proposal.
Environment: The mentoring committee for this proposed K01 award is structured to support my research and
training in sleep, nutrition, stress, mixed-methods research, accelerometry, and using social media for
intervention delivery. Each mentor has extensive mentoring experience and content expertise in critical
aspects of the research and training proposal. The Center for American Indian and Rural Health Equity
(CAIRHE) has provided me with start-up funds, office laboratory space, IT support, statistical support, and 9
months of protected research time each year. In addition, Montana State University is committed to developing
AI faculty and research with a number of institutes and centers that support health and biomedical research,
including CAIRHE (NIH P20GM104417); the Montana IDeA Network of Biomedical Research Excellence, or
INBRE (NIH P20GM103474); the American Indian/Alaska Native Clinical and Translational Research Program
(NIH U54GM115371) among others. CAIRHE, where my office is located, provides an ideal environment for
conducting community-based participatory research in tribal communities throughout Montana with resources,
personnel, and expertise housed within the center. CAIRHE and other MSU research centers house several
senior internal researchers with extensive NIH funding records including my primary mentor and CAIRHE
director Dr. Adams. This optimal research environment will ensure that my transition into an independent
health disparities scientist is successful.
Research: Children sleep less now than ever before. Despite a growing body of literature in understanding
child sleep patterns, sleep interventions are limited. To date, there are no sleep intervention studies that have
been done in AI tribal communities. Elders and community members play a critical role in identifying culturally
adaptive solutions to address problems in tribal communities. Because of the prevalence of historical trauma
and mistrust of outsiders, I am uniquely positioned to do this work in my own tribal community. Preliminary data
of sleep patterns showed that Blackfeet children age 2-5 and age 12-15 averaged 10.15 hours and 7.5 hours
of weekday sleep. Despite this understanding, evidence-based solutions to increase TST in tribal communities
are unknown. Thus, I propose to explore traditional sleep routines coupled with asking Blackfeet families about
the current sleep environment in their home to develop a culturally specific sleep intervention with one child
and one adult dyad. I hypothesize that the sleep intervention will increase TST (primary outcome) in the dyads.
The intervention may also result in improved physical activity and diet, and decreased stress and screen time
(secondary outcomes). Data will be measured at 0 and 9 weeks and then at 3 month follow-up. This
hypothesis will be tested in the following specific aims:
Specific Aim 1: Develop a culturally appropriate sleep intervention for Blackfeet families with K-1st
grade children using surveys, focus groups, interviews, community input, and evidence-based
strategies on sleep.
Specific Aim 2: Feasibility test of the 9-week sleep intervention with K-1st grade Blackfeet families.
The work proposed in these aims is designed to develop a comprehensive understanding of traditional sleep
strategies and the child sleep environment to develop and pilot-test a novel culturally appropriate sleep
intervention in the Blackfeet community. Developing culturally specific interventions to increase TST will
address two significant gaps in the literature; understanding sleep problems in AI children and pilot-testing
culturally adaptive sleep intervention strategies that will inform future research for investigators doing similar
work in AI communities and provide direction for an R01 proposal that is one of the outcomes of this work.

Public health relevance
This project will investigate traditional sleep routines and the current sleep environment in American Indian children to develop a culturally appropriate and novel sleep intervention to increase total sleep time for families with K-1st grade children. The outcomes of this study will provide a comprehensive understanding of a relatively unknown behavior (sleep) in American Indians, show results from a novel sleep intervention in a high risk and underserved population, and will also contribute to the research and training development of an American Indian investigator, all defined missions of NHLBI.